Prenatal Drug Exposure and Adolescent Drug Use: The Role of HPA Axis Regulation

DESCRIPTION (provided by applicant): The purpose of this training proposal is to provide opportunities to learn new, innovative research methods to study the Hypothalamic-Pituitary-Adrenal (HPA) axis system and how it relates to drug use in a prenatally drug exposed group of adolescents. By creating an internship and taking courses focused on salivary bioscience and the stress response, advanced statistical techniques, and drug dependence, and obtaining further training and mentorship geared towards professional development, this training grant offers the opportunity to become an independent research scientist. According to the toxic stress model, early life adversity (ELA) changes the way the brain and neuro-endocrine response functions. The toxic stress model posits that biological predispositions such as prenatal drug exposure (PDE) can alter the development of the brain and the neuro-endocrine response so that the HPA axis may be dysregulated. The main hormone produced by the HPA system is cortisol, and it is a major indicator of the stress response. Chronically elevated levels of cortisol can have deleterious effects on the brain, including deficits in memory, learning, stat regulating capacities, and socio-emotional development. Atypical cortisol patterns have been reported in children living in environments with ELA and are related to adolescent drug use. Very little is known about the interplay between PDE, ELA, the HPA system, and drug use. The proposed research integrates biological, social, and psychological elements, and human development research increasingly requires this approach. The training plan allows for development and integration of these areas and application to an area of research that is now beginning to gain attention because of the far-reaching implications of the stress response (e.g., mental and physical health). The training and research plan achieve NIDA's goals of bringing science to bear on drug abuse and addiction by 1) examining the association between PDE and adolescent drug use and how they both directly and indirectly relate to HPA axis regulation and2) by conducting research across a broad range of disciplines (biological, social, developmental, and psychological sciences).

Public health relevance
Little is known about the impact of prenatal drug exposure on the regulation of the HPA axis and the development of drug use, but HPA axis regulation influences several aspects of child development (e.g., brain, health, psychological well-being) making it a critical area of development to investigate. This proposal integrates biological, developmental, psychological, and social aspects of child development to investigate how prenatal drug exposure is related to adolescent drug use directly and indirectly through early life adversity and the development of the Hypothalamic-Pituitary-Adrenal axis system (e.g., cortisol and stress reactivity). This research has the potential to inform public health policy and intervention programs during many different phases of youth development which contributes to this proposal's relevance to public health.